Mount Sinai Medical Scientist Training Program

The mission of the Icahn School of Medicine at Mount Sinai is to "advance science, medicine, and health care delivery for the benefit of humanity through a culture of excellence, innovation, collaboration, and inclusive diversity. We conduct groundbreaking research; educate and nurture the next generation of exceptional clinicians, researchers, teachers, and leaders; and deliver the most advanced compassionate care with an unwavering commitment to health equity." The Medical Scientist Training Program (MSTP) embodies this mission by training a diverse cohort of clinician-scientists through a rigorous, supportive, and integrated dual-degree program that prepares them for impactful careers in biomedical research and clinical medicine. The MSTP integrates clinical and research training throughout the program, featuring longitudinal clinical exposure during PhD training and a dedicated clinical re-entry course to ensure seamless transitions between program phases. The program provides trainees with a comprehensive foundation in advanced research methodologies, critical analysis, and translational applications while fostering the development of leadership, communication, and professional competencies essential for careers at the intersection of science and medicine. Career development activities, including workshops in leadership, resilience, mentor-mentee training, and professional networking, prepare trainees for diverse career pathways in academia, industry, and beyond. The MSTP supports approximately 96 trainees annually, with typical training grant appointments lasting 2 years. Trainees complete the dual-degree program in an average of 8 years, achieving outcomes such as independent fellowship support, scholarly contributions, and placement in top residency programs. Over 80% of graduates pursue research-intensive careers, with many securing NIH funding and leadership positions across biomedical research sectors. Our recruitment strategy includes program partnerships and targeted outreach to expand access for individuals who may lack it, ensuring a robust applicant pool that reflects the nation’s biomedical workforce needs. The program fosters a safe, accessible, and inclusive environment through comprehensive support services for trainees. Structured mentorship training for faculty further enhances the quality and consistency of support provided to trainees throughout their dual-degree journey. By training clinician-scientists who integrate research, clinical expertise, and leadership, the MSTP contributes to shaping a biomedical workforce prepared to address complex health challenges and drive scientific innovation.

Public health relevance
The Medical Scientist Training Program (MSTP) at the Icahn School of Medicine at Mount Sinai provides a supportive, inclusive, and rigorous dual-degree training environment to prepare physician-scientists to address critical public health challenges. By fostering expertise in biomedical research, translational medicine, and healthcare innovation and promoting collaborative problem-solving and social advocacy skills, the program equips trainees to advance equitable healthcare and improve health outcomes for diverse populations. This integrated approach ensures our graduates are well-prepared to lead transformative efforts in public health and medicine.